Transcriptional Regulators in Aging Macrophages

As key governors of tissue integrity, macrophages are implicated in many age-related diseases. Macrophages
are a plastic myeloid immune cell type found in nearly every tissue of the body where they perform critical
functions for homeostasis. Tissue-resident macrophages adapt to perform specific functions through the action
of tissue-specific transcription factors (TFs) that respond to signals in the local environment. In combination with
cell-type-specific TFs, they specify a distinct epigenomic landscape leading to tissue-specific gene expression.
Changes to the macrophage environment due to systemic inflammation and other signals in aging lead to a
decline in macrophage function. In order to develop preventative strategies, we need a better understanding of
how macrophages are altered in aging. However, parsing out the exact signals responsible and their indirect
effects in an intractable problem. Instead, we have the opportunity to take advantage of functional genomic
approaches to identify the downstream regulators, such as TFs and enhancers, that lead to age-related
dysregulation. In this proposal, we will use macrophages in the synovium of murine ankle joints and
computational approaches to model an aging tissue. The synovial compartment largely consists of long-lived
tissue-resident macrophages but the contribution of monocyte-derived cells that originate in the bone marrow
increases with age. Our preliminary analysis of the age-associated epigenomic landscape of bone marrow
monocytes revealed increased activity of chromatin remodelers and decreased activity of cell-type-specific TFs.
Similarly, we observe a decrease in tissue-resident synovial macrophages in the aging joint and a shift in the
transcriptional profile towards monocyte-derived macrophages. Thus, we hypothesize that the aging synovial
macrophage phenotype is driven by replacement with monocyte-derived cells that fail to acquire tissue-
resident regulators due to epigenomic reprogramming by the aging bone marrow micro-environment. In
Aim 1, we will assess age-associated changes to the synovial macrophage compartment over time. We will
perform ATAC-seq, ChIP-seq, and scRNA-seq on monocyte-derived and tissue-resident macrophages
subpopulations to profile their epigenomic landscape across time. By a combination of clustering and supervised
approaches, we will identify temporal patterns of epigenomic reprogramming and implicate specific TFs that
drive aging in each subpopulation. In Aim 2, we will quantify the impact of cell intrinsic vs. bone marrow micro-
environment on aging monocyte-derived macrophages. Through analysis of their epigenomic profile, we will
identify key enhancers and TFs in their genomic context. Moreover, we will compare the results with additional
chimeras where TNF, one of the key signals in the aging environment, and its receptors are blocked. Together,
these aims will identify key downstream regulators that drive macrophage dysfunction in aging mice with the
ultimate goal of translating of our findings to human patients. Our results will provide a better understanding of
the aging immune system and potential targets for interventions that improve health in aging.

Public health relevance
Macrophages in the joint synovium are key to maintaining homeostasis, but their dysregulation in aging contributes to the development of arthritis. We propose to use genomic approaches to understand how the aging environment alters synovial macrophages on the molecular level. By using mouse models of aging, we aim to identify specific regulators that will provide a target for future therapies.